Characterization of executive function dimensions across pediatric psychiatric disorders

Abstract The supplement requests extension of funding for one year following the end of the parent grant on 4/30/2021, to offset disruption of data collection progress due to covid.

Public health relevance
Project narrative The supplement proposal aims to complete the research started under the parent grant